Schistosoma Mansoni Infection During Pregnancy: Dissecting the Implications to Fetal Immunity

Maternal helminth infections have been implicated in the reduced efficacy of critical life-saving neonatal and
childhood immunizations. Approximately 40 million women of childbearing age are at risk for schistosomiasis
and at least 10 million women in Africa have schistosomiasis during pregnancy, yet little is known about the
impact of prenatal exposure on the immune responsiveness of offspring. Findings from previous studies
indicate that a fetus can be exposed to helminth antigens in utero, so the high frequency of schistosomiasis in
this population represents a significant potential public health problem. The WHO recently recommended
anthelminthic treatments for all pregnant women who test helminth positive; however, very few studies have
evaluated the immunological impact of drug treatment on either the mother or the fetus. Anthelminthic
treatment and the resultant release of parasite antigens have the potential to sensitize a fetus in much the
same way that natural infection does. Given the potentially serious adverse pathological and immunological
consequences of both maternal infection and anthelminthic treatment, it is critical that we understand the
immunological consequences of prenatal helminth infection, so that appropriate recommendations can be
formulated to address any issues with current practices and, ultimately, help to improve immune responses in
infants in resource-poor countries. Our objective in this proposal is to determine the immunological
mechanism(s) through which prenatal S. mansoni infection modulates the homeostatic immune environment,
and the effect this immune-modulation has on post-natal immune responses to antigenic challenge in a mouse
model of maternal S. mansoni infection. Our central hypothesis is that in utero exposure to S. mansoni
antigens reduces the steady-state expression of the co-stimulatory molecules CD21/35, and preconditions
lymph nodes in the developing fetus towards a muted Th2-skewed immune response following postnatal
immunization with immunologically unrelated antigens. We propose three specific aims to test this: 1) Define
the mechanism(s) by which prenatal exposure of mice to S. mansoni infection modulates postnatal peripheral
lymph node homeostasis; 2) Define the mechanism(s) by which prenatal exposure to S. mansoni infection
modulates postnatal cellular immune responses to unrelated antigenic challenge; 3) Determine the
consequences of anthelminthic treatment of infected pregnant mice on postnatal vaccine-induced immunity of
offspring. At the completion of these studies, we expect to have identified key immunological mechanisms that
underlie reduced immunity in offspring born to mothers infected with S. mansoni. It is likely these mechanisms
will include reduced antigen presentation ability and preconditioning of antigen presenting cells and the T cell
compartment towards priming a Th2 response; however even if it is not, we expect to have identified key
mechanisms underlying reduced immunity. Successful completion of these studies can be expected to have a
potentially important future positive impact on strategies for treatment of helminth-infected pregnant women.

Public health relevance
Approximately 40 million women of childbearing age are at risk for schistosomiasis, a chronic Neglected Tropical Disease caused by infection with parasitic flatworms of the genus Schistosoma, and at least 10 million women in Africa have schistosomiasis during pregnancy, but little is known about the impact of prenatal exposure on the immune responsiveness of offspring. Our research is directed towards understanding the immunological mechanisms that underlie reduced vaccine efficacy in offspring from schistosome-infected mothers, with a long-term goal of improving immunological outcomes for both mothers and offspring.